Myosin 18 and its role in skeletal muscle

Myosin 18 and its role in skeletal muscle: H. Lee Sweeney, P.I.
Abstract:
This project will investigate the structure and function of an unconventional myosin, myosin XVIII (Myo18). One
of the two forms Myo18 expressed in vertebrates, Myo18B, is critical for the generation of sarcomeres in
striated muscle. The other form, Myo18A is found in all cells, including muscle, where it may function in other
critical cellular processes that require Myo2 filament recruitment and organization, including the early stages of
sarcomere formation in striated muscle. Mutations that result in the loss of Myo18B result in myopathies in
humans. While Myo18 has been characterized as a non-motor, scaffolding protein, that aids in the assembly of
Myo2 filaments, we postulate that it is in fact an active motor protein subject to a novel form of regulation. Only
by understanding the design and function of this motor, and using those insights to probe sarcomere formation
in muscle cells, will we begin to understand the roles that Myo18 plays in striated muscle and ultimately in
other tissues.

Public health relevance
Myosin 18 and its role in skeletal muscle: H. Lee Sweeney, P.I. Relevance: Myosin 18B is expressed primarily in striated muscle cells, while the closely related myosin 18A is found in all cells, including muscle cells. These myosins are thought to play a critical role in the formation of myosin II filaments and loss of myosin 18B leads to myopathies in humans. The design and function of these motor proteins has not been elucidated and must be in order to understand how they function in muscle formation.